Flow Cytometry Core

All of the Projects of this Program are very heavily dependent on analysis by flow cytometry. The Center for Immunology has a flow cytometry facility that includes one FACScan, two FACSCaliburs (two laser), and two LSR II (four laser) instruments. Funds are requested in the Program Core to insure that the Program investigators have ready access to state of the art reagents and methodologies, and to insure access to adequate data storage and analysis capabilities.